Wildfires and intentional biomass burning in California and Preterm Birth

Project Summary
Preterm birth is an important risk factor for perinatal mortality and adverse health consequences in
childhood and adulthood. In the United States, approximately 10% of all live births were preterm (<37 weeks
gestation) in 2012 and it continues to climb. Fresno County, in the San Joaquin Valley of California, is an area
of known high air pollution burden and a high prevalence of preterm birth (12%).
Wildfires are a significant and increasing source of air pollution in California (CA) that threaten to reverse
the progress made over the past decades in air pollution reduction and their effects on pregnant women are
not well understood. Furthermore, recent fires are occurring at the wildfire urban interface leading to biomass
and structure burning. With increased exposure to wildfire smoke comes increasing concern of health effects of
these exposures to inform future regulation. Other biomass burning sources are agricultural waste burning,
prescribed burns, and residential wood burning which all can increase air pollution exposure but in more
controlled settings and are generally performed during seasons outside the growing fire season. They differ in
scope, temperature and chemical composition and may have less severe health effects compared to wildfires.
We and other investigators have demonstrated preterm birth risk is sensitive to prenatal exposures to
ambient air pollution, including criteria pollutants such as particulate matter and polycyclic aromatic
hydrocarbons, a product of incomplete combustion. Moreover, we have found stronger associations in
neighborhoods with lower socioeconomic status. This double jeopardy of exposure to pollutants and poverty is
hypothesized to contribute to disparities in preterm birth, but sufficient data are often lacking.
To address the contribution of wildfire and other biomass burning smoke exposures on preterm birth, and
how these relationships may be modified by neighborhood deprivation, we propose to compile a unique group
of datasets of fire occurrence, air quality monitoring and modelling, and birth record data for CA (2008-2016) to
evaluate the effects of wildfires and intentional burning (agricultural waste, residential wood, and prescribed
burns) exposure on preterm birth and to evaluate if the effects differ by the Index of Concentration at the
Extreme, a measure of neighborhood deprivation that accounts for extremes based on race/ethnicity and
income by census tract. We will compare different models of fire exposure assessment and examine critical
periods of pregnancy with regard to preterm birth, while controlling for season.
This study will provide estimates of the impact of air pollution exposures from wildfires and other biomass
burning on preterm birth. The findings have the potential to inform fire prevention and protection regulation for
wildfires, agricultural waste burning, prescribed burns, and residential wood burning.

Public health relevance
Project Narrative We propose to study how mothers’ exposures to wildfire and intentional biomass burning during pregnancy may affect whether her baby is born prematurely. We will also evaluate the role of neighborhood deprivation and race/ethnicity may modify the relationship between fire exposures and preterm birth.